Acceptance and Commitment Therapy for Fear of Recurrence in Breast Cancer Survivors

PROJECT SUMMARY / ABSTRACT
Following treatment for early-stage cancer, most survivors fear the possibility of a recurrence. While mild and
intermittent for many, these fears become clinically significant for approximately 40% of survivors, adversely
affecting mood, coping, and quality of life while simultaneously increasing healthcare use and associated
costs. Particularly vulnerable are breast cancer survivors (BCS) who are 33% more likely to report clinically
significant fear of cancer recurrence (FCR) than other survivors. Additionally, FCR is the top unmet need
among BCS, yet evidence-based treatments for FCR are lacking. Cognitive Behavioral Therapy (CBT) has
been the most frequently tested intervention for FCR, yielding modest effect sizes. A theoretically distinct
approach that may be better suited to BCS' experiences with FCR is Acceptance and Commitment Therapy
(ACT). The goal of ACT is to increase psychological flexibility so that difficult internal experiences (e.g., fearful
thoughts and feelings) interfere less with meaningful activities and quality of life. Psychological flexibility is
comprised of mindfulness/acceptance processes (i.e., compassionate attention to the present moment) and
commitment/behavior change processes (i.e., identifying and acting in line with personal values). Our team
conducted a 3-arm pilot randomized controlled trial in BCS with clinical FCR comparing group-based ACT to
an attention-matched survivorship education (SE) group and enhanced usual care (EUC; brief coaching with
self-administered readings). Rapid recruitment (91 BCS in 12 weeks) and high retention (94.5% through 6
months) demonstrated outstanding feasibility. Our 6-week ACT intervention was superior to SE and EUC in
reducing FCR and improving several other outcomes at 6 months post-intervention. Based on these promising
pilot trial results, we propose a 3-arm phase III randomized controlled trial of ACT compared to CBT and EUC
for early stage (I-IIIA) BCS 0-5 years post-treatment (N=375) reporting clinically significant FCR. All
interventions will be delivered via videoconferencing. Using the Indiana State Cancer Registry and Indiana
Network for Patient Care database, we will recruit BCS from five oncology facilities, including one that
specializes in the care of racially, ethnically, and economically diverse survivors. Specific aims are to: (1) test
the efficacy of group-based ACT compared to CBT and EUC on FCR (primary outcome) and anxiety,
depressive symptoms, post-traumatic stress, avoidant coping, and quality of life (secondary outcomes) over 12
months; (2) examine change in psychological flexibility as a mediator of ACT's effects on FCR over 12 months;
and (3) perform comparative assessment of ACT, CBT, and EUC to determine the cost-effective intervention
for FCR. Our ability to demonstrate ACT's efficacy will lead to its widespread dissemination to BCS. Findings
will also inform further application and refined testing of ACT with various cancer populations and health-
related outcomes.

Public health relevance
PROJECT NARRATIVE Fear of cancer recurrence (FCR) is a highly prevalent, disruptive, and under-treated problem for breast cancer survivors. This randomized controlled trial will test the efficacy of group-based Acceptance and Commitment Therapy compared to Cognitive Behavioral Therapy and enhanced usual care for breast cancer survivors suffering from FCR while examining its cost-effectiveness and the mechanisms by which the intervention may work. Study findings will guide the future care of breast cancer survivors with FCR.